Adipose Tissue Reprograms Acute Lymphoblastic Leukemia Cells to Facilitate CNS and Bone Invasion

PROJECT SUMMARY
Obesity is associated with an increased risk of relapse from acute lymphoblastic leukemia (ALL), the most
common childhood cancer. We have uncovered a novel mechanism by which fat tissue may make ALL more
aggressive and harder to cure. ALL cells found in adipose tissue in mouse models have a higher expression of
RANKL (receptor activator of nuclear factor kappa-B ligand) than ALL found in marrow. Exposing ALL cells to
adipose tissue ex vivo also increases their expression of RANKL. RANKL is known to contribute to ALL cell
expansion in vivo, as well as invasion into bone and the central nervous system (CNS). In the present grant, we
will investigate the pathways by which adipose tissue increases ALL expression of RANKL. We will explore this
finding using a translational approach, with experiments ranging from bench to mouse to evaluations of clinical
samples. We will elucidate which adipose tissue-derived signals are responsible for ALL cell RANKL expression.
We will examine whether obesity increases ALL RANKL expression in mice and clinical samples, and explore
the relationships between RANKL expression and bone density, CNS invasion, and chemotherapy treatment
response. Finally, we will test an FDA-approved treatment, denosumab, in mice to see whether impairing RANKL
signaling can improve ALL treatment outcome. These studies may provide a novel strategy for ALL patients to
reduce bone loss and fractures, reduce CNS invasion, and potentially improve chemotherapy treatment
outcomes.

Public health relevance
PROJECT NARRATIVE Patients with acute lymphoblastic leukemia (ALL) who are obese have a much higher risk of relapse than those who are not obese. We found that fat tissue induces expression of a protein called RANKL in ALL cells, which might contribute to this poorer outcome. In the present study, we are investigating how this occurs as well as strategies to intervene.